Echogenic Targeted Liposomes: Transfection/Drug Delivery

PROJECT SUMMARY/ABSTRACT
Atherosclerotic peripheral arterial disease affects 202 million people worldwide and leads to serious
health complications, including limb amputation. Peripheral arterial stent implantation ameliorates flow,
but ~15% of patients lose patency within a year following treatment due to in-stent and peri-stent restenosis
Traditional means to treat arterial disease are hampered by their inability to direct therapeutics to local
atheroma components. Direct delivery results in high local bioavailability with decreased dose and toxicity.
Pioglitazone is a peroxisome proliferator-activated receptor-gamma (PPARγ) agonist that reduces
pro- inflammatory cytokines and generates anti-inflammatory and anti-arteriosclerotic effects. We have
developed a novel methodology for local delivery of pioglitazone loaded into fibrin-targeted echogenic
liposomes (Atheroglitatide). We are able conjugate a fibrin-targeting peptide to the outer surface of
the lipid bilayer, encapsulate octafluoropropane to provide echogenic properties, and include pioglitazone
in sufficient quantities to stabilize the stented artery and attenuate the surrounding peri-stent neoatheroma.
The use of ultrasonic catheters (EKOS™ Endovascular System (Boston Scientific, Corp., USA))
provides a localized source for therapeutic delivery and ultrasonic penetration to augment atheroma
stabilization in the arterial bed at the time of intervention. We have previously demonstrated that therapeutic
efficacy was concomitant with ultrasound (US)-mediated bubble activity, or cavitation.
We have developed an atheroma stabilization strategy using pretreatment with nitroglycerin followed
by infusion of fibrin-targeted pioglitazone-loaded ELIP into stented peripheral arteries using clinically
translatable compounds. We demonstrated sustained cavitation nucleated by atheroglitatide infused
through the EKOS™ catheter driven with the endovascular system, an FDA-approved ultrasonic delivery
system.
In these studies, we will complete final product determination and demonstration of effective
cavitation nucleation for tissue penetration without causing local tissue damage.
Together, these results will provide IND-enabling studies and translation to first in human trials.

Public health relevance
PROJECT NARRATIVE This proposal seeks to demonstrate that pulsed ultrasound facilitates therapeutic delivery of targeted pioglitazone loaded echogenic immunoliposomes to stabilize peri/in-stent restenosis at the time of intervention.